DATA ANALYTICS, STATISTICAL AND BIOINFORMATIC ANALYSIS AND TOOL DEVELOPMENT, Genome wide association studies (GWAS)

TASK AREA C: DATA ANALYTICS, STATISTICAL AND BIOINFORMATIC ANALYSIS AND TOOL DEVELOPMENT, Genome wide association studies